ADMISSION HEART RATE PREDICTS COMPLICATIONS IN MYOCARDIAL INFARCTIONS

Patients with inferior myocardial infarction often have sinus bradycardia. A heart rate of 70 bpm could represent a relative tachycardia in the patients and identify a group at high risk for complications of the infarction.